Monoclonal Antibody Therapeutics for Candida auris

SUMMARY
In the past decade Candida auris has emerged a new pathogenic fungus that causes disease
associated with high morbidity and mortality. C. auris has an intrinsic resistance to azoles and
polyenes, leaving echinocandins as the only reliably effective class of antifungal agents.
Unfortunately, drug resistance to echinocandins is rising rapidly and there is an urgent need for
new antifungal drugs and new approaches to therapy. This project proposes the pre-clinical
development of mAb-based therapy against C. auris. In recent decades mAbs have emerged
as major therapeutic agents in medicine but they are relatively underused in the field of
infectious diseases. Antibody therapies have a storied history for the treatment of infectious
diseases and there is considerable evidence that they are active against Candida spp.,
including C. auris. Immunotherapy in the form of mAbs makes sense because most C. auris-
related disease occurs in debilitated individuals with impaired immunity and antibody therapies
provide immediate immunity. Furthermore, antibody therapies represent a fundamentally
different form of antifungal therapy than that associated with small molecule drugs and thus
provide the opportunities for synergy and additivity with existing therapies. Unfortunately, no
mAbs to C. auris have been made and relatively little work has been done to understand
humoral and cellular immunity to this increasingly important fungal pathogen. Hence, we
propose to generate a suite of new mAbs to identify suitable candidates for clinical
development and will study their mechanisms of action and efficacy in combination with the
three classes of antifungal drugs. Three Aims are proposed: 1) To generate a large repertoire
of mAbs to C. auris surface determinants; 2) To identify protective mAbs to C. auris and
establish their mechanism of action; and 3) To identify the most effective mAb combinations
with antifungal drugs. This project will deliver mAbs for future clinical development, provide a
new understanding of the mechanisms of antibody-mediated protection against C. auris and
create an immunological knowledge base that is essential for the development of immune
mediated therapies and vaccines.